HIV/AIDS CLINICAL RESEARCH TRAINING PROGRAM

DESCRIPTION (Applicant's Abstract): The complex biomedical, psychological, neuropsychiatric, psychosocial, and sociocultural challenges associated with the HIV/AIDS epidemic are such that there continues to be a critical need for specialists in HIV/AIDS clinical research. This application proposes the development of a training program to provide comprehensive postdoctoral clinical research training in the HIV/AIDS mental health and behavioral science arena for psychiatrists and clinical psychologists. Through the creation of a training infrastructure consisting of an interdisciplinary collaborative faculty, the program would: (1) provide broad HIV/AIDS clinical research training through didactic seminars and involvement in research projects, and (2) offer specialized training along one of three pathways: applied mental health research, behavioral interventions research, or research linking basic science investigation to clinical areas. The program will be located in the Emory University Department of Psychiatry and Behavioral Sciences with key training linkages throughout the Emory University School of Medicine, Rollins School of Public Health, Yerkes Regional Primate Research Center, Centers for Disease Control and Prevention, and Georgia State University. The diversity of the program faculty and resources permit innovative research pursuits with clinically, ethnically, and culturally diverse populations of HIV-seropositive and HIV-affected individuals and groups. The overall goal of the proposed clinical research training program is to train clinical researchers who could then meaningfully contribute to the future scientific agenda for HIV/AIDS mental health and behavioral science research.